Validation of a Semi-Automated Infection Surveillance Algorithm for Electrophysiology Procedures

The ultimate goal of this project is to improve cardiovascular health by using advanced clinical informatics to identify procedure-associated cardiac implantable electronic device (CIED) infections. This is important because cardiac device infections are a common, highly morbid and costly complication of electrophysiology procedures, yet no standardized infection prevention programs exist to reduce them. Surveillance with feedback is an important aspect of infection prevention programs. Detection of infections allows problems to be identified and policies and procedures refined to improve practice and clinical outcomes. This I21 project will use flags left in the VA electronic medical record as part of diagnosis and treatment to identify cardiac device infections. In Aim I, a preliminary electronic CIED infection detection tool will be refined. In Aim II, the infection detection tool will be validated on a large, national cohort of VA patients. Future IIR proposals will measure the impact of implementing a surveillance system on CIED infections and will assess how information from surveillance systems can be used to improve outcomes. The PI, Dr. Branch-Elliman, is ideally suited to conduct the proposed work. Her background developing advanced medical informatics tools based on diagnostic and therapeutic pathways to detect other types of healthcare-associated infections within the VA healthcare system and expertise in infection prevention and antimicrobial stewardship in the cardiac electrophysiology laboratory greatly enhance the probability of success. The Specific Aims are: Specific Aim I: To improve the receiver operating characteristics (ROC) of the CIED infection detection tool to >0.85 using the existing Clinical Assessment Reporting and Tracking (CART-EP) database (~1500 manually reviewed cases). Structured variables that are part of the diagnostic and therapeutic pathway for managing CIED infections (e.g., antimicrobial orders, consult orders, microbiology results, laboratory results) will be tested to determine their impact on the ROC value and a refined tool will be developed. Specific Aim II: To test and validate the clinical informatics-based infection detection tool on FY 2016-17 data available in the VA Corporate Data Warehouse (CDW) (> 14,900 cases). The electronic detection tool will be applied to the CDW cohort and approximately 1000 charts will be selected for manual review to determine the presence/absence of infection. These 1000 charts will include an equal number of high, intermediate, and low probability cases. Cases categorized incorrectly by the infection detection tool (i.e., infection cases scored as low probability and non-infected cases scored as high probability) will be reviewed to identify the reason for the discordance. These findings will be used to inform a future implementation. Site-level performance variation will also be measured. Future Directions: A future IIR proposal will implement the tool in the 15-hospital Infection Control and Prevention Practice-Based Research Network (ICCPPBRN) to measure the impact of an electronic infection detection system on clinical outcomes and to measure how surveillance with feedback changes policies and practice. Impact: Expansion of infection prevention to currently uncovered outpatient areas, such as the electrophysiology laboratories, is important for improving patient safety. This research closes an important gap in the care of cardiovascular patients while also providing important insights into methods to expand surveillance of healthcare-associated infections to include outpatient areas.

Public health relevance
Innovative approaches are needed to reduce healthcare-associated infections, which rank among the top-ten causes of death in the United States. As the population of Veterans ages, the prevalence of cardiovascular disease has increased, leading to an increase in the number of procedures carried out to implant cardiac devices (pacemakers and implantable cardioverter-defibrillators). At the same time, there has been an increase in the number of cardiac device infections, which have an absolute six-month mortality of up to 18%. Long-term goal of this clinical informatics project is to improve the health and longevity of veterans by reducing cardiac device infections through development and implementation of pragmatic novel infection prevention interventions tailored for outpatient settings and procedural areas, such as the electrophysiology laboratory.